CONSENT-ASL Toolkit for Deaf and Hard of Hearing People

There is a critical need for a user-centered, accessible informed consent toolkit. The
purpose of this G08 application is to develop and deploy an accessible informed consent app-
based toolkit to support two target audiences: 1) deaf patients who wish to participate in
research studies and 2) clinical research coordinators (CRCs) and principal investigators (PIs)
who do not have the resources to make their informed consent materials accessible to
prospective participants who are deaf.
This project is low-risk and high in impact because it builds on the leadership team’s
research with the medically underserved Deaf community. Knowledge gained from the
proposed activities will therefore have great potential to bring useful, usable resources to deaf
signers and who wish to participate in research or clinical trials.
Finally, the resulting resources will fill a gap prioritized in Goals 1&2 of NLM's Strategic
Plan Goals because the proposed work will support research through information
dissemination strategies that enhance information delivery of research participation and
informed consent to underserved, overlooked groups such as deaf people who use ASL.

Public health relevance
PUBLIC HEALTH RELEVANCE This application will design a linguistically accessible CONSENT-ASL toolkit and test its reach, effectiveness, adoption, implementation, and maintenance in research and clinical trials. 1